Cancer Center Support Grant - Gunn Supplement

Abstract/Project Summary: This application is being submitted in response to the Notice of Special Interest
(NOSI) identified as "NOT-CA-24-041.” Dartmouth Cancer Center (DCC) is one of the only NCI-designated
Comprehensive Cancer Center serving a primarily rural catchment area, with 81% of patients living in rural
areas. The catchment population has a higher cancer incidence relative to the U.S—leading to a relatively
large population of cancer survivors served by DCC. With the 2024 release of the National Standards for
Cancer Survivorship Care, cancer centers—including DCC—now have a framework by which to assess and
implement survivorship programming to improve outcomes in care, including engagement of survivors in
follow-up care. Several studies show that engagement in survivorship care is associated with better overall
well-being and cancer-related outcomes. Yet, survivorship care must tackle a diverse set of clinical and non-
clinical needs, including risk of cancer recurrence, increased risk of developing other cancers, late treatment
effects, impacts to mental health, and reduced quality of life and functional capacity. Receipt of survivorship
care is inversely associated with distance to care, an issue further compounded by transportation and financial
challenges common among rural survivors. Though care has traditionally been provided in-person, the new
national standards acknowledge the importance of telehealth and digital delivery of care, which may be
especially important in rural areas with longer travel times to in-person services. In this proposed study, we will
assess the alignment of DCC’s survivorship program with the 2024 standards, identify gaps, and examine
opportunities for expanding engagement of survivors through promising digital health interventions. Using a
quality improvement framework, we will conduct an environmental scan of DCC’s survivorship program to
identify gaps and opportunities by inventorying program components, the extent to which components have
been fully implemented, and use by survivors. In assessing utilization, we will summarize and compare
demographic (e.g., age, gender, rurality) and clinical (e.g., cancer stage/type, time since treatment)
characteristics between survivors engaging in survivorship care with those not engaging. We will also conduct
surveys (n=200) and qualitative interviews (n=25) with cancer survivors to elucidate perceived barriers and
facilitators to receiving survivorship care, unmet needs, input on how DCC’s survivorship program could best
meet survivor needs, and perspectives on digital health tools to incorporate into DCC’s survivorship program.
To ensure sustainability and translation of the findings, we will convene a broad group of cancer survivorship
stakeholders to review and interpret the study findings. Through consensus building sessions stakeholder
groups will develop recommendations for enhancements to DCC’s survivorship program, including
implementation of digital tools to expand access to services, particularly for DCC’s rural survivor population.

Public health relevance
Project Narrative Even after completing cancer treatment, cancer survivors have increased health risks compared with the general population, necessitating ongoing care through survivorship programs. This project will assess Dartmouth Cancer Center’s survivorship services against a new set of national standards for survivorship programs to identify areas where Dartmouth Cancer Center’s program can be enhanced to meet rural survivors’ needs and engage them in care through digital tools and other innovative solutions. The project will produce a set of recommendations for quality improvement initiatives to support lasting impacts on survivorship care delivery and outcomes for survivors in rural areas.